Co-Design and Pilot Testing of Peer-led Community Outreach to Improve Equity, Veteran-Centeredness and Uptake of Lung Cancer Screening

Background: Lung cancer screening (LCS) with annual computed tomography can reduce lung cancer
mortality, but <10% of the estimated 1 million eligible Veterans have been screened, with lower rates among
Black people. Many barriers prevent Black people from engaging in LCS: lack of awareness of LCS or how to
access it, stigma, fatalistic expectations about lung cancer, power differentials with providers, mistrust of VA,
limited self-efficacy, and adverse social determinants of health [entrenched by structural racism]. As a result,
across the US LCS uptake is 50% lower [and adherence is 20% lower] among Black vs white persons.
Significance: Fourteen Veterans die of lung cancer each day (5000/year), and Black men have the highest
incidence and mortality in the US. To improve equity, the 2022 President’s Cancer Panel recommends using
trained community peers (known in VA as Peer Specialists, or “Peers”) to reach vulnerable individuals where
they are and support them in engaging in cancer screening. Our overarching hypothesis for this line of
research is that community outreach, education, and tailored one-to-one support delivered by Veteran Peers
can address barriers that prevent Black Veterans from accessing LCS, thereby closing disparities.
Innovation & Impact: We will use co-design with Black Veterans, Peers, and community partners to develop
an innovative, Veteran-centered intervention (Peer-led program) that meets the needs of Black Veterans. No
prior research has tested VA Peer Specialists in such a role. This work is tightly aligned with Office of
Research & Development priorities on health equity and precision oncology. The 2022 HSR&D priorities call
for health equity studies and for pilot studies testing strategies for Veteran and community engagement.
Specific Aims: This pilot project has the following aims: 1) Co-design the Peer-led program in partnership with
Veterans and community stakeholders; 2) Assess feasibility and acceptability of the Peer-led program; and 3)
[Establish feasibility of study procedures].
Methodology: In Aim 1, we will convene a virtual co-design team of 1-2 Peers and 5-7 Black LCS-eligible
Veterans from across the US, [including at least 2 Black women and Veterans varying in age, ethnicity, and
geographic residence. Using best practices for equity-centered co-design], we will create a plan and messages
for community outreach, content for group LCS orientation, and the process for one-to-one Peer coaching and
navigation to support Black Veterans to engage in LCS. We will seek input from our community partners, [the
National Association for Black Veterans and Tri-Ad Veterans League], external Veteran advisory panels, and
LCS clinical staff to ensure relatability beyond our team and fit with clinical workflow. In Aim 2, we will conduct
a feasibility pilot test of the Peer-led program. The Peer will lead up to 4 group LCS orientations in community
partner sites to reach ~40 LCS-eligible Black Veterans. The Peer will provide one-to-one tailored support to 15
Veterans (e.g., coaching, goal-setting, navigation to access VA LCS). We will evaluate program delivery with
Peer periodic reflections and activity logs. We will interview Veteran participants, community partners, and LCS
clinical staff to explore feasibility and acceptability of the Peer-led program and solicit suggestions for
improvement. Aim 3 will pilot test and refine study procedures to be used in the IIR: enrolling Veterans;
administering surveys to assess change in Social Cognitive Theory constructs; and extracting LCS uptake and
tobacco treatment 3 months post-enrollment from VA’s Corporate Data Warehouse.
Next Steps/Implementation: This work will inform a multi-site stepped-wedge trial (IIR) to assess
effectiveness, implementation, and cost of the Peer-led program in VA LCS sites and neighboring [branches of
the National Association for Black Veterans]. Our operational partners in the National Center for Lung Cancer
Screening, Office of Health Equity, and Peer Specialist Services are committed to disseminate the Peer-led
program to reduce disparities in LCS and lung cancer outcomes, in line with VA’s 2022-28 Strategic Plan.

Public health relevance
Lung cancer is the leading cause of cancer death among Veterans, and Black men have the highest rate of lung cancer diagnoses and deaths of any group in the US. Lung cancer screening with yearly chest scans can prevent lung cancer deaths, but only 10% of eligible Veterans have been screened, with lower rates among Black people than white people. Outside the VA, trained community peers are effective to increase cancer screening rates among minority populations. In this pilot project we will develop a Veteran Peer Specialist-led program to support and empower Black Veterans to engage in lung cancer screening. The Peer-led program will be designed with input from Black Veterans and will include community outreach, group education, and one-on-one support personalized to the needs of individual Black Veterans. We will pilot test this program in the VA Boston Healthcare System in partnership with local community organizations that serve Black Veterans. This pilot work will allow us to refine the Peer-led program and to plan a subsequent multi-site study.